Investigating the contribution of a novel monocyte transcriptional state to sepsis immunopathogenesis and patient heterogeneity

Project Summary/Abstract
Sepsis is characterized by life-threatening organ failure caused by dysfunctional immune
responses to infection; however, the specifics of immune dysfunction are poorly understood and
vary widely among patients. Single-cell RNA sequencing (scRNA-seq) enables gene-level
analysis of individual immune cell responses during sepsis and has the potential to provide
transformational understanding of sepsis immunopathogenesis. Recent studies using this
approach identified a novel monocyte transcriptional state, termed monocyte substate 1 (MS1),
which was enriched in a small exploratory cohort of patients with urosepsis. Preliminary scRNA-
seq analysis of serial blood samples from patients with all-cause bacterial sepsis (i.e., sepsis
from various infectious sources) demonstrates a decline in MS1 monocytes early in sepsis that
is inversely correlated with CD4+ T and CD8+ T cell kinetics. Further analysis shows enrichment
of the MS1 gene signature in a subtype (or “endotype”) of patients with an immunosuppressed
response during sepsis.
This project will apply scRNA-seq and functional immunological assays to investigate the
immunomodulatory role of MS1 and its contribution to patient heterogeneity in sepsis. The
findings have the potential to advance understanding of sepsis immunopathogenesis, resolve
phenotypic heterogeneity, and guide development of subtype-specific treatment strategies.
The candidate is an Instructor in Medicine at Harvard Medical School and Assistant in
Medicine in the Division of Infectious Diseases at Massachusetts General Hospital (MGH). He
has prior doctoral training in investigations of microbial population and evolutionary dynamics
within human hosts. This proposal expands his scientific scope to include transcriptomic,
computational, and functional analysis of host immune responses to infection. He will conduct
his research under the co-mentorship of Dr. Nir Hacohen and Dr. Roby Bhattacharyya at the
Broad Institute of MIT and Harvard. The proposal includes a five-year career development plan
with research content, didactic and hands-on training in computational genomics and systems
immunology, and career advisement from a committee of established scientists with
complementary expertise. The proposed training will equip the candidate with the skills, data,
and publication portfolio needed to establish an independent research career as a physician-
scientist with a niche investigating pathogen and immunological heterogeneity in infections. The
ultimate goal is to contribute to the development of precision therapies in infectious diseases.

Public health relevance
Project Narrative Sepsis is characterized by life-threatening organ failure caused by dysfunctional immune responses to infection; however, the specifics of immune dysfunction are poorly understood and vary widely among patients. This project investigates single-cell transcriptional responses of immune cells during sepsis, focusing on the kinetics and immunomodulatory role of a novel monocyte transcriptional state and its contribution to patient heterogeneity. The insights gained will advance understanding of sepsis pathophysiology and support stratification of patients into subtypes, enabling the identification of those most likely to benefit from targeted therapies.